Community Engagement and Outreach Core

Community Engagement and Outreach Core Project Summary / Abstract.
The long-term goal of the Community Engagement and Outreach (CEO) Core is to strengthen community-
engaged clinical and translational (C&T) research throughout the state by supporting investigators in
developing effective and sustainable health research projects that respond to community-informed needs and
priorities. To achieve this goal, we will implement a shared leadership model by establishing a Montana Health
Issues and Priorities (M-HIP) Community Advisory Board (M-CAB) to guide CEO Core efforts, including a
statewide assessment of health research priorities (Aim 1). We will provide C&T investigators with training,
mentoring, and actionable tools to inform the success of their outreach and engagement activities with diverse
populations across the state (Aim 2). To support the sustainability of community-engaged C&T research
efforts, both during and beyond the project period, we will formalize a Practice-Based Research Network of
clinical and public health practice sites, and provide Montana Clinical and Translational Research Center
investigators with opportunities to disseminate their research findings to a broad audience throughout the state
(Aim 3).